The Family Check-Up Online: Development of an asynchronous training program for providers to enhance wide-scale dissemination

Project Summary/Abstract
Substance abuse is rising due to multiple factors, with over 20 million adults seeking treatment for substance
use disorders (SUD) every year. Increasing rates of substance abuse, depression, and anxiety during COVID-
19 coupled with reduced access to mental health care have culminated in a critical need for evidence-based,
telehealth interventions to support families and reduce digital inequities in treatment delivery for populations at
high risk. Research suggests a developmental pathway to SUD that includes problem behavior in early
childhood and disrupted family relationships that lead to deficits in self-regulation and risk behavior during
adolescence and adulthood. This pathway to SUD’s can be disrupted through effective prevention. In response
to this critical need, we have developed the Family Check-Up Online (FCU Online), a digital, web-based
application designed to support parents and children in the development of parenting skills and reduction of
stress and other risk factors associated with a range of long-term outcomes, including substance abuse.
In the proposed application, we will develop and test an asynchronous, online training program for health care
providers that will lead to large-scale dissemination of the FCU Online model in community settings. We will
develop the product with a series of interviews that will guide the development and content of the training
modules. We will then test the training program with 20 providers who will give feedback on the feasilbity and
acceptability of the training model in real-world settings. Our team includes experts in implementation and
dissemination, evidence-based interventions for at-risk families, business development and marketing, and
product development. Letters of support from primary care and community health providers demonstrate our
strong partnerships that will facilitate this research. The study will significantly contribute to our understanding
of mobile ehealth interventions for families and children at risk of SUD to reduce digital inequities and barriers
to delivery of evidence-based interventions in community settings.

Public health relevance
Project Narrative This application focuses on examining the feasibility and commercial potential of an asynchronous, online training for a digital, web-based application for families of children at-risk for substance use in a range of community health settings. By interviewing providers, developing an online training program, and conducting usability and feasibility testing, we plan to evaluate a training model for the Family Check-Up Online product in order to promote wide-scale dissemination of this evidence-based treatment to community mental health and primary care organizations.